GLYCOGEN STORAGE DISEASE--BIOCHEMICAL DIAGNOSIS, PROGRESSION AND THERAPY

The purpose of this study is to investigate 1) the effects of various dietary treatments or disease progression in the glycogen storage diseases (GSD), 2) the molecular basis of type III GSD, and 3) the mechanism of renal disease associated with type I GSD.